Application of Modern Methods to Predict Risk and Estimate Treatment Effectiveness in Cardiogenic Shock

PROJECT SUMMARY/ABSTRACT
Acute myocardial infarction complicated by cardiogenic shock (AMI-CS) is a major driver of global
morbidity and mortality. Due to the challenges of conducting randomized trials for these acutely ill patients, the
evidence for mechanical circulatory support devices (MCS) commonly used to treat AMI-CS is limited, resulting
in a lack of consensus on optimal treatment strategies and consequent wide variation in care practices. Thus,
improving our understanding of whether and how recently published randomized trials of MCS should influence
contemporary clinical practice, as well as applying rigorous observational approaches to understand the causal
effects of MCS devices in purposefully designed shock registries would fill critical gaps in our current
understanding of AMI-CS management. The overarching goal of this grant is to apply state-of-the-science
methods to a combination of clinical trial and observational cohorts to identify the optimal use of MCS
devices in AMI-CS. In Aim 1, we will append individual patient data from recent landmark clinical trials of MCS
devices to several contemporary cardiogenic shock registries including the Cardiogenic Shock Working Group
(CSWG) Registry, the American Heart Association’s Cardiogenic Shock Registry, and the American College of
Cardiology’s CathPCI Registry. To these appended datasets, we will apply novel transportability methods to
first evaluate the applicability of the trials’ results to contemporary U.S. practice, and then extend inferences
from the trial to new clinically relevant target populations. In Aim 2, we will evaluate the safety and
effectiveness of MCS device treatment for AMI-CS in the CSWG and AHA Shock Registries through application
of the target trial framework. We will take advantage of the collection of detailed time-stamped hemodynamic
parameters, laboratory values, and device treatments in these unique registries, and apply grace-period
cloning approaches that can account for dynamic changes in patient status to examine the effects of
alternative treatment approaches in AMI-CS. In Aim 3, we will apply traditional and machine-learning
approaches to assess heterogeneity of treatment effects of MCS use among patients with AMI-CS and develop
tools to create individualized estimates of treatment benefit and harm. “Effect score” models will be developed
and validated within the CSWG and AHA Shock, and applied to randomized trial data to identify heterogeneous
treatment responses. This research has the potential to fill critical gaps in our understanding of the benefits
and risks associated with mechanical circulatory support devices for the treatment of AMI-CS, leveraging the
application of innovative methodological approaches to multiple powerful new datasets. The insights gained
from this knowledge may lead to improvements in the care and outcomes of individuals with this highly morbid
cardiovascular condition for which evidence remains scant and randomized clinical trials are unlikely to be
conducted soon.

Public health relevance
PROJECT NARRATIVE Heart attacks (myocardial infarction) can lead to significant damage to heart function, resulting in a state of shock that is often lethal. This study will examine data collected in both randomized trials as well as newly designed registries of patients with heart attacks and shock to identify which patients benefit the most from the use of emergency heart pumps, and which others might be harmed by their use. The research has the opportunity to generate high-quality evidence to guide the management of a high-risk cardiovascular condition that causes tens of thousands of deaths each year.